Biomagnetic characterization of gastric dysrhythmias

DESCRIPTION (provided by applicant): Electrical activity in the stomach underlies functional physiology and pathophysiology. Our preliminary data show that the magnetic fields associated with the gastric slow wave contain critical parameters that help to characterize rhythms and may be important indicators of gastropathy. While both the electrogastrogram (EGG) and the magnetogastrogram (MGG) contain frequencies that correlate well with myoelectric potentials in the gastric musculature, additional spatiotemporal information in the MGG allows assessment of gastric propagation. We have shown that MGG propagation characteristics differ when comparing normal subjects with gastroparesis patients. We have also been able to compute the propagation gradient of the gastric syncytium from noninvasive MGG measurements and have shown its correlation with serosal electrode data. To continue our research on the magnetic fields of the stomach, we are proposing: (1) to use a realistic abdominal volume-conductor model to study how abdominal thickness affects EGG and MGG data and how normal and uncoupled gastric musculature affects EGG and MGG patterns. Data from our studies contradicted our original hypothesis that body mass index (BMI) significantly affects these signals, which was based on theoretical studies that predict such influences from abdominal layers. We will utilize the model developed under this aim in the analysis of our experimental data from the other specific aims. (2) We propose to determine how gastrectomy affects EGG and MGG. The normal intact stomach produces slow wave propagation patterns observable with MGG. We hypothesize that although non-gastric signals may appear near the gastric slow wave frequency range, these signals will not exhibit the same gastric propagation. (3) We will determine how gastric uncoupling changes MGG propagation patterns by inducing uncoupling surgically or pharmacologically to measure the changes in propagation and coupling assessed by EGG and MGG. (4) We will correlate the degree of gastroparesis with abnormal patterns of MGG propagation. We showed that a variety of abnormal propagation patterns characterize gastroparesis and we will determine whether these pattern differences differentiate the severity of the disease. (5) Finally, we will determine whether similar differences exist between diabetic and idiopathic gastroparetics, and we will determine how much variation exists between patients. The ability to consistently evaluate the electrical activity of the stomach in terms of both frequency dynamics and propagation characteristics will help us to better understand underlying pathologies that will in turn inform and direct better and more effective treatment options for gastroparesis patients, and ultimately for patients suffering a variety of gastric disorders. PUBLIC HEALTH RELEVANCE: The magnetogastrogram (MGG) measures both the frequency content and spatiotemporal dynamics of underlying gastric slow wave electrical activity in health and disease. Pathological conditions like gastroparesis may not affect frequency content commonly measured by EGG, but do alter propagation patterns detected by MGG. The ability to noninvasively characterize gastric slow wave abnormalities will ultimately lead to a deeper understanding of gastric pathology and will inform treatment protocols.

Public health relevance
Specific Aims For more than 100 years, researchers have recognized the potential value of noninvasive methods to assess bioelectrical activity. The electrogastrogram (EGG) has been around nearly as long as the electrocardiogram (EKG) (1), but in contrast to the heart, which is relatively well-understood as a bioelectromechanical system, the fundamental electrophysiology of the gastrointestinal system remains ambiguous. With the discovery nearly 30 years ago that interstitial cells of Cajal (ICCs) provide the putative mechanism for both pacing and propagation of electrical activity in the stomach and intestine (2-5), researchers have realized that many GI disorders can be traced to disruption of the normally well-coupled syncytium formed by these cells. Consequently, there is renewed clinical interest in the potential utility of noninvasive detection methods to characterize the normal and pathologic physiology of the stomach. With EGG, the low amplitude of the gastric slow wave combined with volume conduction effects in the abdomen causes both attenuation and smearing of the signal amplitude and spatial frequency content (9-11). Our studies show consistently that the magnetogastrogram (MGG) records information not available in the cutaneous EGG. Our lab has established that the noninvasive MGG correlates with serosal electromyogram recordings in frequency content and in propagation characteristics. We have developed techniques that allow us to analyze slow wave uncoupling and propagation which provides, for the first time, a measure to distinguish normal and pathologic gastric electrical activity. Our primary hypothesis for this revised proposal is that analysis of gastric slow wave uncoupling and propagation in multichannel MGG discriminates between normal and pathologic gastric electrical activity. Our specific aims and hypotheses are: Specific Aim 1 - Assess EGG and MGG propagation in the abdominal volume conductor. Hypothesis 1a: A mathematical model demonstrates that abdominal thickness obscures propagation in EGG and not in MGG Hypothesis 1b: Propagation parameters determined by edge-detection and wave mapping of MGG patterns correlate with similar parameters in source models and serosal electrodes Specific Aim 2 - Determine how partial and total gastrectomy affect EGG and MGG signals and MGG propagation patterns. Hypothesis 2a: Partial gastrectomy decreases the amplitude of both EGG and MGG but does not change the signal frequency. MGG propagation patterns reflect the reduced conduction pathway created by partial gastrectomy. Hypothesis 2b: Total gastrectomy eliminates signals near 3 cycles per minute in both EGG and MGG and abolishes MGG propagation patterns. Specific Aim 3 - Determine how gastric uncoupling changes MGG propagation patterns. Hypothesis 3: Severe gastric uncoupling causes rotation, stasis, and retrograde propagation in MGG patterns and decreases the percentage of slow wave coupling (PSWC) in cutaneous EGG, but moderate uncoupling affects only MGG signals. Specific Aim 4 - Identify correlations between MGG propagation pattern abnormalities and degree of diabetic gastroparesis. Hypothesis 4a: Static, retrograde and rotational MGG propagation patterns occur in diabetic gastroparesis while MGG propagation patterns in diabetics without symptoms of gastroparesis are similar to those of normal controls. Hypothesis 4b: Poorly controlled diabetics with gastroparesis exhibit more abnormal MGG propagation patterns but do not show differences in EGG percentage of slow wave coupling (PSWC) when compared to well-controlled diabetics and normal controls. Specific Aim 5 - Determine differences in EGG coupling and MGG propagation patterns as a measure of coupling in idiopathic and diabetic gastroparesis and their intra-subject variation. Hypothesis 5: Analysis of abnormal MGG propagation patterns allows consistent distinction of diabetic and idiopathic gastroparesis.